Trial of Exercise and Lifestyle (TEAL) in Women with Ovarian Cancer

Project
Abstract/Summary
Ovarian
ethnicity.
chemotherapy.
chemotherapy.
chemotherapy
ancer (OC) is the most lethal gynecologic malignancy, with disparities in survival by race and
Nearly all stages of OC require aggressive treatment, such that
First-line treatment includes surgery and six cycles of latinum- and taxane-based
Timely and successful completion of chemotherapy is critical, as delayed or reduced
dosage for OC is associated with decreased survival; yet
c
90% of women diagnosed receive
p
chemotherapy dose delays and dose
reductions are common. The primary reason for dose delays and reductions is chemotoxicity, including
neuropathy, cognitive dysfunction, fatigue, depression, arthralgia, and gastrointestinal toxicities. Muscle loss is
an additional consequence of chemotherapy in women with OC. Strategies to manage chemotoxicities include
nutrition and exercise. Our team has extensive experience in leading multi-site nutrition and exercise
interventionsin women with OC andrelevant experience with trials specifically addressing chemotherapy
completion rates. We will leverage this expertise to address a critical gap: how to reduce chemotoxicity and
treatment delays in women with OC. We propose to conduct a
medical
sample
assess Aim 1: Relative dose intensity (RDI), an integrated measure of
chemotherapy dose delays and reductions; Aim 2: Patient-reported chemotoxicities including neuropathy,
cognitive function, depression, fatigue, arthralgia, and gastrointestinal disturbances; Aim 3: Body composition
multi-site randomized trial of an 18-week
nutrition therapy and exercise intervention vs. attention control in a racially and ethnically diverse
of 00 women newly diagnosed with OC (stage I-IV) and initiating curative intent chemotherapy to
the effect of the intervention on:
2
and muscle mass assessed via CT scans and urinary D3
‐ Creatine
dilution method; and Aim 4: Long-term
lifestyle behaviors, body composition, patient-reported chemotoxicities, and health care utilization assessed 3-
months post-intervention and 12-months post-diagnosis. We hypothesize women randomized to intervention
will have higher RDI as compared to women in the attention control arm because of fewer patient-reported
chemotoxicities. The intervention will result in attenuated declines in body composition compared with attention
control, and women randomized to the intervention will maintain healthy lifestyle behaviors long-term, in turn
favorably impacting lingering chemotoxicities and body composition, resulting in less health care utilization
compared with attention control. Strengths of our approach is that baseline, follow-up visits and the intervention
duration are timed with standard of care in that first-line chemotherapy is completed at ~18 weeks (when our
primary endpoint will be assessed) with women undergoing repeat imaging assessments at this timepoint and
3 months later. Positive results would accelerate a paradigm shift with OC patients receiving nutrition and
exercise programming as standard of care in tandem with chemotherapy treatment to minimize chemotoxicity
and optimize treatment dose delivery for a curative outcome.

Public health relevance
Project Narrative Ovarian cancer (OC) is the most lethal gynecologic malignancy, with 90% of women diagnosed receiving chemotherapy. Timely and successful completion of chemotherapy is critical as delayed or reduced chemotherapy dosage for OC is associated with decreased survival, yet chemotherapy dose delays and dose reductions are common (~30% to 50% of OC patients), with the primary reason for dose delays and reductions being chemotoxicity. We propose to conduct a multi-site randomized trial of an 18-week medical nutrition therapy and exercise intervention vs attention control in a racially and ethnically diverse sample of 200 women newly diagnosed with OC (stage I-IV) and initiating curative intent chemotherapy to assess the effect of the intervention on chemotherapy completion rates, patient-reported chemotoxicities, and body composition.